Prodrug Formulations Create Sustained-Release Antiretrovirals

Abstract
Long acting (LA) therapeutics offer real potential for improved regimen adherence and disease outcomes for
chronic infectious diseases. For human immunodeficiency virus (HIV) infections only cabenuva has emerged as
a sole complete LA regimen to affect long-term viral suppression. However, the requirements for every two-
months dosing, injection site reactions, health care practitioner administration, high dosing volumes, and
prolonged “tail phase” pharmacokinetic (PK) profiles are challenges for broad use. Ultra-LA (ULA) therapies are
therefore obvious next step needs. Such ULA antiretroviral therapies (ART) would increase dose intervals to
simplify treatment, limit emergence of viral mutations through improved adherence to therapy, and synchronize
regular six-month lab tests clinic visits with dosing. In our prior funding cycle we developed then licensed one of
the “first” ULA antiretrovirals. It is a monomeric stearate ester of cabotegravir (CAB, named XVIR-110), a potent
HIV integrase strand transfer inhibitor. We are pleased to affirm its clinical candidate selection status for HIV-1
prevention. XVIR-110 has a projected dosing interval of beyond every six months. The formulation has
successfully completed IND-enabling GLP toxicity studies for a planned Phase I clinical trial and found to be
safe. With this success as a foundation we now present our next research goal. It is to develop a next generation
ULA ART that favorably addresses the needs for combinatorial ULA regimens, shorten the PK tail in existing LA
formulations and XVIR-110, and further decrease injection volumes. In support of each goal is extensive
preliminary data offered through the selection of homodimeric bictegravir (BIC) ester prodrugs demonstrating
superiority over dolutegravir (DTG) and CAB. We posit that process chemistry design and development for the
lead BIC dimer prodrug and prodrug design for rilpivirine (RPV) and tenofovir (TFV) will produce a complete six
month dual therapy (BIC/RPV and BIC/TFV) for treatment of HIV-1 infection. Drug choices, prodrug and
formulation development, in vitro and in vivo screening and mechanisms, toxicology, PK, and pharmacodynamic
profiles will follow comprehensive Go-No Go criteria that advanced XVIR-110. To accomplish our research
goals, a partnership was made between a medicinal and polymer chemist (B Edagwa) and a virologist, cell
biologist, and immunologist (H Gendelman). Our complementary team has a strong history of collaboration and
will continue to leverage on technical and scientific support from Exavir Therapeutics Inc. and Gilead Sciences.
We posit that harnessing of natural viral target cells (monocyte-macrophages and CD4+ T cells) as drug carriers
and depots will improve treatment outcomes. We will use a milestone-driven approach to identify and advance
the most promising six month complete two drug regimen towards clinical translation.

Public health relevance
Project Narrative We seek to develop a six-month complete two drug regimen for HIV-1 treatment. Our aims are to improve adherence to life saving medicines and reduce the likelihood of viral transmission.